EFFICACY &SAFETY OF SYGEN VS PLACEBO TREATMENT IN ACUTE SPINAL CORD INJURY

The objective of this study is to determine the efficacy and safety of two doses of Sygen in the treatment of patients with acute spinal cord injury.